THE ION SELECTIVITY OF THE EXCITABLE MEMBRANE

Squid giant axons injected with arsenazo III as an intracellular Ca indicator will also be treated with TTX and TEA to pharmacologically block Na and K currents and will then be voltage clamped from a variety of resting potentials initially specified by changing the [K] in seawater. The family of curves for internal Ca vs. membrane potential will allow one to characterize the dependence of [Ca] in axoplasm on membrane potential. Other measurements will examine the dependence of Ca efflux on membrane potential. Finally, the factors influencing the inactivation of Na/Ca exchange in squid axons will be examined.